Targeting ADAM17 maturation in resistant hypertension.

With prevalence as high as 55% for individuals aged 55 and older in United States, hypertension (HTN) is a
major risk factor contributing to cardiovascular diseases (CVD) and global mortality, hence remaining an
increasingly important medical and public health issue. The role of the brain renin-angiotensin system (RAS) in
the maintenance of normal blood pressure (BP) and in the neuro-cardiovascular dysregulation leading to HTN
has been firmly established. Angiotensin (Ang)-II, by means of its type 1 receptor (AT1R), promotes increased
sympathetic nerve activity, salt and water reabsorption, vasoconstriction, aldosterone and vasopressin release
and inflammation, all contributing to HTN. While numerous overexpression studies, from our group and others,
have established the benefits of ACE2 (Angiotensin Converting Enzyme type 2) in preventing the progression
and improving the treatment of HTN in experimental models, our group was the first to demonstrate that ADAM17
(A Disintegrin And Metalloprotease) mediates ACE2 shedding in neurogenic HTN, thus reducing ACE2
compensatory activity in mice and humans. ADAM17-mediated ACE2 shedding, a process by which the protein
ectodomain is cleaved from the plasma membrane and secreted into the surrounding milieu, has since been
confirmed in many tissues including heart and kidney. ADAM17 is thought to mediate neuroinflammation through
soluble TNFα, IL-6 trans-signaling, CX3CL1 and other cytokines, yet this mechanism has not been studied in
neurogenic HTN. DOCA-salt HTN is associated with increased levels of TNFα, IL-6 and reduced ACE2 activity
in the brain, while deletion of ADAM17 from neurons reduces BP, restores ACE2 activity and decreases pro-
inflammatory cytokines. Although ADAM17 is thought to be a major drug target for inflammation, the
development of selective inhibitors has failed. Recent work, deemed revolutionary, shows that ADAM17
maturation is tightly regulated by rhomboid proteins in the brain (iRhom1 in neurons and iRhom2 in microglia),
opening the door for novel targeting strategies. Accordingly, we hypothesize that targeting ADAM17 maturation
will reverse sympatho-excitation and neuro-inflammation in neurogenic HTN. We will test this new
targeting strategy in the following two specific aims.
Using a combination of human stem cells-derived neurons and microglia, unique transgenic and conditional
knockout mice, with selective deletion of ADAM17 in microglia (Cx3Cr1ERT2-ADAM17tom) and targeted
knockdown of ADAM17 maturation in neurons (Rhom1) or microglia (iRhom2), the immediate objectives of this
application are to: 1) Understand how ADAM17 upregulation takes place throughout pre-sympathetic networks;
2) Assess the feed-forward role of ADAM17 in neuro-inflammation and microglia activation; and 3) Test new
clinically-relevant targeting strategies to prevent ADAM17 activation and the development of resistant HTN.

Public health relevance
Over activity of the brain renin-angiotensin system (RAS) has major deleterious effects in the development and maintenance of cardiovascular diseases (CVD), particularly in hypertension, which affects 55% of individuals above age 55 in United States. Based on our previous work, ADAM17-mediated shedding is a novel and unexplored mechanism leading to a loss of compensatory ACE2 (angiotensin converting enzyme type 2) activity but also an increase in pro-inflammatory cytokines in hypertension and CVD. Targeting the maturation of ADAM17 will be investigated both in vitro and in vivo in order to determine the overall benefits for the treatment of hypertension.